Project 2

PROJECT ABSTRACT The SARS coronavirus-2 (SARS-CoV-2) has rapidly emerged over the past four months leading to a critical pandemic of coronavirus disease (COVID-19) with over 1.4M cases worldwide (https://coronavirus.jhu.edu/map.html) and roughly 100,000 projected fatalities in the US alone by August 2020 (See https://covid19.healthdata.org/projections). SARS-CoV-2 causes a lethal ARDS. Despite our improved mechanistic understanding of ARDS, intervention clinically is challenging. NOT-AI-20-31 indicated several needs, such as development of reagents and assays for virus characterization, understand critical aspects of viral infection, replication, pathogenesis, and transmission, identification and evaluation of the cellular and humoral immune responses to SARS-CoV-2, which we address in this proposal. Indeed, there is an urgent need to understand the immunopathology of COVID-19 and study the interactions of the lung epithelium and tissue, the immune system and the virus to understand the biology of this multipartite interaction. We need to better understand the immunopathology of COVID-19 to explore novel therapeutic approaches that have the potential to work in COVID-19 patients. Our proposal addresses this need from the perspective of the lung epithelium response to SARS- CoV-2 infection and from a T cell perspective in COVID-19. Simultaneously, or efforts will also provide a sharable research platform of lung airway organoids/SARS-CoV-2/immune cells that will expedite testing of experimental therapeutics. Results from my supplement program will be shared with Drs. Gordon, Looney, and Krummel in our “RapidPath” program (see supporting letter) to promote rapid discovery and progress and will be compared to insights from COVID-19 patient immune systems, being simultaneously profiled in the UCSF IMPACC project. In this this Administrative Supplement we will capitalize on my lab’s established expertise in T cell signaling, T cell activation, antigen recognition, inflammation, and autoimmune diseases. Those are broad topics of the parent P01 (2P01AI091580, Weiss). Uniquely, we will combine our T cell expertise with our expertise in the generation and studies of epithelial cell organoids. We already have an “Airway Organoid Biobank” that we will expand as a resource for the community. We will characterize the epithelial response to six different SARS-CoV-2 strains compared to H1N1pdm virus, using airway organoid-, single cell RNAseq-, and CyTOF- technology (Aim 1). In order to better understand SARS-CoV-2 and adaptive immunity, we will obtain mechanistic insights into T cell activation and T cell signaling in the context of SARS-CoV-2- and H1N1pdm- infection of seven, diverse Airway Organoids and two NSCLC organoids (Aim 2). High-resolution imaging and CyTOF analysis of these “virus-T cell-organoids” will provide much needed immunological insights into SARS-CoV-2 and its T cell biology as indicated in NOT- AI-20-31 and will synergize with other projects in “RapidPath” and in UCSF IMPACC programs.

Public health relevance
PROJECT NARRATIVE The SARS coronavirus-2 (SARS-CoV-2) rapid emergence has led to a critical pandemic of coronavirus disease (COVID-19) with over 1.4M cases worldwide, creating an urgent need to understand the immunopathology of COVID-19 and study the interactions of the lung epithelium with the immune system. The goal of this Administrative Supplement is to characterize the lung epithelial response to infection by different sub-strains of SARS-CoV-2 and to obtain a comprehensive overview of T cell activation and T cell signaling in the context of SARS-CoV-2 versus H1N1 influenza infection of Airway Organoids. The proposed research will provide a resource “Airway Organoid Biobank” with detailed single cell RNAseq- and CyTOF- characterization of SARS-CoV-2- versus H1N1pdm- infection and obtain mechanistic insights into CD4+ and CD8+ T cell responses to SARS-CoV-2, needs that are indicated in NOT-AI-20-31.